DNA TRIPLE HELICES &EXPANSION OF TRIPLET REPEATS

Expansion of the GAA/TTC triplet repeats inside the first intron of the frataxin gene causes an autosomal disease named Friedeic's Ataxia. In normal phenotypes, 7-30 triplet repeats of GAA/TTC are present, whereas in disease phenotypes more than 200 copies appear and the mRNA of the frataxin gene is totally absent. It is our hypothesis that the formation of an unusual DNA structure by the GAA/TTC repeat causes its expansion and that this unusual structure is stabilized by higher repeat lengths. This also suggests that the formation of these same unusual structures during transcription causes the suppression of the mRNA synthesis. In this project, we have chosen a GAA/TTC sequence that forms a triple helix structure. In this triplex structure, the TTC strand folds back around the GAA strand and one side of the GAA strand interacts with the TTC strand via Watson-Crick base-pairing, whereas the other side of the GAA strand uses Hoogsteen base-pairing. We have started to measure 2D NMR experiments to determine the high resolution structure of this triplex. We plan to identify the nature of the TTC folding and the conformation of the three individual strands in the triplex. These studies will help us visualize how such a triplex structure can be formed during replication and transcription.